Health Promotion and Disease Prevention Research Centers

Project Summary/Abstract
Rural Americans face major health disparities and differences in overall health status, higher rates of chronic
disease, geographic isolation, and limited job opportunities. Recent data shows that US rural areas do not
experience the consistent decline in premature mortality that non-rural locations do. West Virginia (WV), a highly
rural state, exemplifies these disparities and inequities. WV ranks at or near the bottom in many US health
indicators (e.g., cardiovascular and cancer morbidity/mortality) and their associated risk factors (e.g., obesity,
tobacco use). WV is also at the epicenter of the US opioid crisis. Since 1995, the WV Prevention Research
Center has been a transformative force that conducts and translates innovative community-engaged research
and evaluation into practical solutions to improve health in WV and beyond. Together with our committed and
experienced Community Partnership Board, we propose a Research and Translation Agenda that builds on
our expertise in substance use/abuse (especially tobacco and opioids), promotes healthy lifestyles, and fosters
youth and community resilience. This Agenda reflects the priorities of our partners and emphasizes policy and
practice translation. Our experience with development and national dissemination of the evidence-based teen
smoking cessation program, Not on Tobacco, for the American Lung Association, demonstrates our capacity to
conduct, translate, and disseminate proven interventions to diverse communities. Our previous partnerships and
accomplishments position us for the next 5 years of growth and achievement. We propose to achieve this
through the following Specific Aims: 1) sustain and enhance a multidisciplinary infrastructure, inclusive of a
statewide Community Partnership Board, that conducts, translates, and disseminates innovative, community-
engaged research and evaluation; 2) engage multi-stakeholder partners to develop, implement, and sustain a
Research and Translation Agenda, inclusive of a Core Research Project; 3) strengthen the capacity of public
health practitioners, health care providers, faculty, staff, students, and communities to conduct and apply
prevention research to address public health priorities and disparities through training and service provision;
4) disseminate WVPRC capacity, products, and findings; and 5) participate in the National PRC Network. Our
proposed Core Research Project uses a cross-sequential design to address risk and protective factors
relevant to youth and community resilience against substance use initiation and progression in middle- and
high school-aged youth. This research project is in the public health practice-based evidence research
category, incorporates health equity approaches, and attends to the goals of sustainability and scalability. Our
intended outcomes include a sustained Center infrastructure; increased capacity in prevention research; and
environmental, policy, and practice changes that result in practical, sustainable solutions that improve
population health and vitality for years to come.

Public health relevance
Project Narrative West Virginia, our target population, ranks at or near the bottom in many US health indicators (e.g., cardiovascular and cancer morbidity/mortality) and their associated risk factors, and is at the epicenter of the US opioid crisis. The WV Prevention Research Center, inclusive of a highly committed and experienced Community Partnership Board, will collaborate with state and local health departments and other multisector partners to conduct applied public health research, evaluation, technical assistance, and training. Our intended outcomes include a sustained PRC infrastructure; increased capacity in prevention research; and environmental, policy, and practice-based changes improve population health.